Minnesota Training Program in Virology

7. Project Summary/Abstract
This is a competitive renewal of the “Minnesota Training Program in Virology” following a highly productive
funding period. Discoveries in virology research have led to many fundamental insights into molecular and
cellular processes of cells, basic mechanisms of viral replication and pathogenesis, and strategies for how host
cells respond to viral infection (i.e., virus-host interactions). Viruses and their capacity to cause serious diseases
and death have had a profound impact on the history of humanity and continually threaten global health and
economic stability. This was dramatically emphasized by the COVID-19 pandemic. This training program utilizes
44 accomplished preceptors, who are conducting research on a wide variety of important viruses. The Institute
for Molecular Virology (IMV) serves as the focal point for virology research at University of Minnesota (UMN) and
has championed virology research as a critically important university investment at a time of declining institutional
resources. Such investments in the past decade have included a 80,000-square-foot, $63 million Microbiology
Research Facility that opened in 2015 as well as $25 million for additional research infrastructure.
Key highlight’s of the training activities of our program in the current funding segment include the creation of a
virology-dedicated graduate course designator and the implementation of foundational coursework in virology
as well as a wide-range of IMV-sponsored activities attended by both trainees and preceptors that provide
important intellectual, technical, and career development opportunities (i.e., weekly Virology Journal Club,
monthly IMV Research in Progress seminars, quarterly IMV Innovations in Virus Research Lecture Series,
annual UMN-Mayo Distinguished Lectures in Virology & Gene Therapy, the IMV Educational and Career
Development Series, the annual IMV Symposium, a collaborative ‘Wisc-e-sota’ T32 symposium, and annual
sessions in Responsible Conduct in Research). Trainee participation in these training program activities have
fostered the exchange of ideas and stimulated collaborative projects. Oversight of trainee progress is monitored
on multiple levels, including yearly evaluations by the training program Executive Committee.
Outstanding predoctoral trainees are attracted to the UMN. From this pool, outstanding predoctoral trainees are
recruited to preceptor labs by the individual strength of each preceptor’s research program. Trainee recruitment
is enhanced by the breadth of career development opportunities provided through the IMV that include the
hosting of national and international virology meetings that brings students – including students from
underrepresented populations – to our campus to develop long-lasting interactions with all members of our
virology research community. The program has developed a strong record of training achievement. To fulfill our
training mission with our available resources, we request support for 5 predoctoral positions per year for the next
5-year funding period.

Public health relevance
8. Project Narrative The training of young scientists that will become the next generation of virologists is essential for our nation’s capacity to respond to existing, emerging, and future viral diseases. Furthermore, research on viruses continues to lead to fundamental discoveries in biology. Through the Institute for Molecular Virology and this T32 program, the University of Minnesota – Twin Cities campus has established itself as a leader in virology research, with strengths in biophysical virology, cancer virology, influenza virus, herpesviruses, along with emerging and other highly pathogenic viruses.